Repurposing FDA-Approved MEK Inhibitor Trametinib for Protection Against Cisplatin-Induced Hearing Loss

Project Summary/Abstract
Hearing loss caused by cisplatin ototoxicity affects 40-60% of chemotherapy patients resulting in decreased
quality-of-life and debilitating language barriers, yet no Food and Drug Administration (FDA)-approved
treatment is currently available. Current compounds in preclinical and clinical trials provide only partial
protection or are associated with life-threatening side effects, thus there is a clear need alternative treatment
strategy. Recently, BRAF inhibitor dabrafenib was found to protect from cisplatin toxicity in vivo when
administered at clinically relevant doses. Additional inhibitors of the mitogen-activated protein kinase (MAPK)
pathway, including MEK inhibitor trametinib, also protect from cisplatin toxicity in cochlear explant models.
Importantly, a combination of dabrafenib and trametinib is FDA-approved for treatment of melanoma and may
be fast-tracked for treatment cisplatin-induced hearing loss. The compounds are also effective against brain
metastases, revealing they cross the blood-brain barrier which is similar to the blood-labyrinth barrier in the
ear. We therefore hypothesize trametinib will protect against cisplatin-induced ototoxicity in vivo and
provide enhanced protection in combination with dabrafenib. In aim 1, we will determine whether MEK
inhibitor trametinib confers protection from cisplatin-induced ototoxicity in mouse models. We will test whether
oral trametinib mitigates cisplatin ototoxicity in CBA mouse models using a clinically relevant multi-dose, multi-
cycle treatment model. Hearing loss will be determined by measuring auditory brainstem response (ABR) and
distortion product otoacoustic emission (DPOAE) threshold shifts, along with morphological analysis of
cochlear HCs, supporting cells, stria vascularis, and SGNs. Verification of trametinib-mediated MAPK pathway
inhibition will be obtained by immunostaining of adult mouse cochleae. Confirmation trametinib crosses the
blood-labyrinth barrier achieved by above mentioned immunostaining and Mass Spectrometry (LC-MS) of
perilymph samples from trametinib treated mice. In aim 2, determine if a combination of trametinib and
dabrafenib provide enhanced protection from cisplatin-induced ototoxicity We will test the drug combination’s
protection from ototoxicity, regulation of the MAPK pathway, and ability to cross the blood-labyrinth barrier as
described in aim 1. This study will be the first to investigate the potential of trametinib, and combination of
trametinib with dabrafenib, for protection against cisplatin-induced hearing loss as we seek to provide a robust
therapeutic candidate for a disorder with no current FDA-approved treatment. Moreover, Creighton hosts 7
auditory research labs who regularly collaborate on projects, joint meetings, and seminars. Additionally,
Creighton’s Translational Hearing Center has been awarded an NIH-affiliated Centers of Biomedical Research
Excellence (COBRE) grant to translate basic hearing loss research into practical therapies. It will allow for
expansion of core facility equipment as well as recruit new research faculty. Thus, Creighton provides an
excellent environment and support for junior scientists seeking to build a career in the auditory research field.

Public health relevance
Project Narrative Cisplatin chemotherapy leads to hearing loss in 40-60% of patients, severely impacting patients’ overall quality of life and creating a debilitating barrier to language development while no treatment is currently Food and Drug Administration (FDA)-approved. This project seeks to repurpose the FDA-approved anticancer MEK inhibitor trametinib, alone and in combination with dabrafenib, for protection against cisplatin-induced hearing loss. Successful completion of the project will provide a novel treatment strategy that may work with cisplatin to promote tumor remission, while providing critical protection of patient hearing.